Coeus: An information tool to support safe admission to the nursing home

Abstract
More than 28 million patients are discharged from the hospital to a nursing home (NH) each year. The transition
from hospital to NH is fraught with difficulties and is disruptive to residents’ care and well-being. A review of
recent hospital to NH transfers found that nearly 40% of residents experienced an adverse event within 45 days
of discharge. NH staff rely on information collected in these acute care settings to safely admit and initiate care
for patients. However, unfortunately the transition process is plagued by poor information exchange. Discharge
paperwork often lacks key information such as imaging study results or antibiotic stop dates, includes out of date
information and is not organized to support decision making in the NH. There is a critical need to develop a
solution that provides key information to NH providers at the time of admission. Probari, an Indiana-based small
business dedicated to improving the quality of NH care through supportive clinical solutions, and its partners at
Indiana University’s Regenstrief Institute, are developing Coeus, a NH-facing transfer application to fill this
significant gap in the market. Using the national Fast Health Interoperability Resources (FHIR) standards for
querying and sharing health data and the Substitutable Medical Applications and Reusable Technologies
(SMART) platform, Coeus will be integrated into NHs’ electronic health records (EHRs) to fit within provider
workflows and to support commercial distribution and will quickly gather and display relevant information from
recent acute care admissions. Once developed, Coeus will increase NH efficiency, increase staff and provider
satisfaction, and improve resident safety including impacting quality metrics such as reduced hospital
readmissions. This Phase I project will demonstrate feasibility with the following Aims: Aim 1. Establish the
information and design requirements for a user-centered FHIR-based transfer application in a NH setting. NH
staff will participate in discussions and a multi-disciplinary design workshop to determine how best to organize
information to support decision making and functional requirements. Aim 2. Implement end-user design
requirements and build the Coeus prototype. Aim 3. Establish the usability of the Coeus prototype. Probari will
deploy the Coeus prototype in a simulated EHR sandbox environment and assess its usability among end users.
At the end of Phase I, Probari will have demonstrated the overall feasibility and usability of Coeus among
potential NH end users. Phase II will focus on deployment of a minimally viable product into a clinical workflow
to evaluate potential impact in preparation for commercialization. Coeus meets a clinical care need and has
market opportunity by supporting NH-based healthcare providers’ access to the information that enables higher
quality care. Once fully commercialized, Coeus’ primary market will be the 15,600 NHs in the US.

Public health relevance
Narrative Millions of patients are discharged from hospitals to nursing homes every year and these transfer are unnecessarily risky due to poor communication across settings of care. Hospital discharge paperwork often lacks key information needed by nursing home providers to provide safe and effective care, such as accurate medication lists or lab results. This project will support the development of a nursing home-facing transfer application that provides critical and timely patient information to fill this significant gap in the market.